Efficacy of a Smartphone-based Just-in-Time Adaptive Intervention to ReduceDrinking among Adults Experiencing Homelessness

PROJECT SUMMARY/ABSTRACT
Approximately 1 out of every 3 adults experiencing homelessness has a current alcohol use disorder (AUD).
Alcohol use plays a central role in increased morbidity and mortality in this population, with some studies
suggesting it plays a direct role in as many of 17% of deaths. Alcohol is also the leading cause of
homelessness and contributes to its chronicity by inhibiting progress towards obtaining employment and a
stable living environment. Shelter-based treatments are common, but compliance is often poor. There are
many documented challenges to effectively implementing traditional evidence-based interventions in shelter
settings. Smartphone ownership and use are now widespread even among unhoused adults, with a 2017
estimate indicating that the majority own a smartphone. This number is likely to continue increasing with the
availability of government subsidized smartphones and service (i.e., Lifeline program). Technical literacy and
interest in technology-based interventions are similarly high. Smartphone-based treatments may offer unique
benefits for this population, given the many barriers to seeking and accessing traditional treatments. The
proposed project will build upon preliminary data that were collected in our recently completed NIAAA R34
study. This study identified environmental, cognitive, and behavioral antecedents to alcohol use, used this
information to develop an algorithm for delivering tailored messages based on imminent drinking risk, and then
conducted a pilot trial in 41 adults experiencing homelessness. Results indicated intervention feasibility and
acceptability and the intervention corresponded with a 50% decrease in alcohol use from baseline. In the
proposed project, we seek to scale this preliminary work by conducting a randomized controlled trial. Adults
currently experiencing homelessness who report hazardous alcohol use (N = 600) will be recruited from five
shelters across the Dallas, TX and Oklahoma City, OK metropolitan areas. Individuals will attend screening
and training visits, then complete one week of self-monitoring (via smartphone app) before being randomized
to receive either standard shelter-based treatment (Usual Care; UC), or the Smart-T Alcohol intervention + UC.
The Smart-T Alcohol intervention offers on-demand content and automated contextually tailored messages to
reduce alcohol consumption. The intervention period will span eight-weeks (i.e., weeks 2-9), with follow-up
assessments occurring at weeks 9, 13, and 26. All participants will complete brief daily smartphone-based
surveys for 13 weeks. Aims of the project will be to assess the effects of the Smart-T Alcohol intervention on
alcohol use and alcohol-related problems (Aim 1), intervention effects on key drinking risk indicators and their
mediation of use outcomes (Aim 2), and identify specific subpopulations (e.g., women, racial/ethnic minorities,
younger adults; Exploratory Aim 3) for which the intervention is most effective. Findings will provide a rigorous
evaluation of the efficacy of the Smart-T Alcohol intervention and guide future smartphone-based interventions
for this population.

Public health relevance
PROJECT NARRATIVE Homeless adults have higher rates of disease, shorter life expectancies, and higher health care utilization compared to housed individuals, all of which are partially attributable to the disproportionately high rate of harmful alcohol use in this population. This project will test the efficacy of a novel smartphone-based just-in- time adaptive intervention specifically designed to work in concert with traditional shelter-based services to address problematic alcohol use in adults experiencing homelessness in a large-scale randomized controlled trial. If effective, this low-cost and highly scalable smartphone-based intervention could significantly improve drinking outcomes, quality of life, and overall health for this highly disadvantaged population.